P30 Admin Sup to Enhance (SOGI) Data Collection

In the state of Michigan, four percent of the state's population identify as a sexual or gender minority (SGM). In
Michigan, the SGM population experiences distinct challenges, which include being more likely to be
unemployed, have experiences of food insecurity and less likely to receive routine healthcare compared to
non-SGMs in the state. It is also likely that these experiences influence the cancer care and outcomes of SGM
populations. In order to better, understand cancer health disparities across SGM populations, systematic and
accurate data collection methods of sexual orientation and gender identity (SOGI) data are needed. At
Karmanos Cancer Institute (KCI), work has started related to SOGI data collection, but additional information is
needed to identify all the potential points of SOGI data collection in the system. Additionally, barriers exist at
the oncology-provider level and patient-level, as well as a lack of understanding and education at each of these
levels for the rationale related to SOGI data collection. Thus, we propose a project to better understand how
SOGI data collection is currently being collected at KCI and the opportunities to improve SOGI data collection
at three KCI network sites in Detroit, Bay Region (Bay City) and Central Michigan (Mt. Pleasant). Specific aims
are to 1) identify oncology provider-level and patient-level barriers to collection of SOGI data; 2) develop and
conduct trainings for oncology providers and staff on rationale and strategies for SOGI data collection; 3)
develop and implement a patient-facing campaign to increase patient awareness and knowledge of SOGI data
collection; 4) implement and evaluate SOGI data collection via both paper-based forms and electronic medical
records at three Karmanos Network sites.

Public health relevance
Project Narrative In the United States, thirteen million people identify as a Sexual and Gender Minority (SGM), however there is a striking lack data for this population, especially in terms of cancer care and outcomes. Systematic and accurate sexual orientation and gender identity (SOGI) data collection is needed to address the distinct challenges faced by the SGM population. The proposed project would contribute to the fundamental knowledge of the barriers and facilitators to SOGI data collection at the oncology provider, hospital staff, and patient level, as well education for oncology providers, hospital staff and patients to better understand the rationale and importance of SOGI data collection.